Leveraging Bifactor Modeling to Test Prospective Direct and Mediational Effects of Adolescent Alcohol Use and Externalizing Symptoms on the Neurobiological Development of Executive Functioning

7. PROJECT SUMMARY/ABSTRACT Adolescence is a period of substantial brain maturation30. Considering the neurobiological development that occurs during this period, a central concern to researchers, policy makers, and parents is the impact of adolescent alcohol use (AU) on cognitive capacities critical to life success, like executive functioning (EF). EF refers to a family of top-down mental processes that support concentration, attention, and behavioral regulation44. Healthy development of EF is essential for mental and physical health, academic achievement, and success in life31,32. It has been proposed that adolescent AU produces physiological and neurobiological events that derail healthy EF development18,30. However, support for this association has been mixed8,35. Equivocal support may be due to (1) failure of past work to consider AU in the broader context of externalizing symptoms and social development33-35, and (2) lack of neuroimaging and behavioral task measures of EF20,36. Adolescent AU often occurs in a broader context of externalizing symptoms (rule-breaking, aggression) and other drug use38, and there is evidence that externalizing symptoms disrupt healthy development of EF through a developmental cascade that involves poor adaptation across multiple contexts (parenting, peers, school)16,17. Co-occurring drug use may also have direct neurotoxic effects that derail EF7,13,18. Hence, poor EF that has been attributed to the neurotoxic effects of adolescent AU may actually be due to these other co-occurring behaviors. Additionally, equivocal support for the AU-EF association may be due to considerable heterogeneity in measurement of EF36. No ??process-pure?? measures to assess EF exist102. Therefore, multimethod approaches are essential102 and theories of addiction assert that it is critically important to use neuroimaging and task methods to measure EF101. This fellowship seeks to provide clarity to the AU-EF literature. We propose to (1) distinguish general externalizing symptoms from domain specific symptoms (including AU, aggression, rule-breaking, drug use) using sophisticated longitudinal bifactor modeling, (2) examine prospective associations between general externalizing symptoms and domain specific symptoms, and EF (measured by fMRI and a behavioral task) across adolescence and early adulthood, and (3) examine whether poor adaptation across several social contexts (parents, peers, and school) mediates associations between externalizing symptoms and deficits in EF. A high-risk longitudinal sample (N=3,337) of children of alcoholics from the Michigan Longitudinal Study will be used to test the proposed aims46. Data will include self-reports of AU, drug use, externalizing symptoms, and social functioning, and an EF behavioral task during fMRI scanning at four waves spanning early adolescence to early adulthood. Our longitudinal data will allow us to examine when risk and protective factors to EF may be especially salient, informing the timing of interventions. Results will advance our understanding of how AU and co-occurring externalizing symptoms, and social adaptation impact trajectories of EF development, and may identity important intervention targets to promoting healthy EF.

Public health relevance
8. PROJECT NARRATIVE The proposed longitudinal study will enhance our understanding of how adolescent alcohol use, other drug use, externalizing symptoms, and social development impact the neurobiological development of executive functioning (EF). Results may identify important intervention targets that can inform policy and prevention programs that aim to promote healthy EF during adolescence and early adulthood. Identifying unique risk pathways to poor EF is of great public health interest because healthy EF is essential for mental and physical health, academic achievement, and success in life.